Multidisciplinary Surgical Decision Making for Older, High Risk Patients

Project Summary
Current surgical consent practices are inadequate for older adults undergoing high-risk procedures. A
true understanding of the long-term health complications of an operation is difficult to achieve in one
conversation. To address this issue, our institution implemented a multidisciplinary preoperative decision-making
conference in 2016. To create a more patient-centric discussion, we started including patients in these meetings
in January 2022. Our pilot data has led us to the conclusion that multidisciplinary discussions for high-risk
surgeries in older adults should be the paradigm for decision-making in these complex situations. This
GEMSSTAR proposal is designed to understand the impact of including older adult patients and caregiver(s) in
a multidisciplinary preoperative discussion and to use a shared decision-making framework to optimize the
meeting structure.
The aims of this proposal are to:
1)Identify communication practices of healthcare providers during multidisciplinary high-risk surgical decision-
making discussions that facilitate or limit patient/caregiver engagement.
2)Determine the impact of older adult and caregiver(s) participation in multidisciplinary group discussions on
their high-risk surgical decision
3)Identify critical components to ensure healthcare provider engagement in multidisciplinary high-risk
discussions with patients.
With the support and expertise of the Denver VA HSR&D, we will be able to clarify the benefits of these
discussions and refine the structure model for multidisciplinary surgical decision-making conferences.
Successful completion of this project will allow Dr Jones to become an expert in surgical decision-making to
apply for a VA Career Development Award and further disseminate this model of care.

Public health relevance
Project Narrative This proposal aims to investigate and optimize multidisciplinary preoperative surgical decision-making discussions for older adults. The proposal's results will introduce a new model for communication between older adults, their caregiver(s) and healthcare professionals to make informed, patient-centric decisions about high- risk operations. The proposed project and education plan will allow the candidate to become an independent investigator with a career goal of redesigning surgical decision-making for high-risk older adults.